Discovery of Multimodal Biomarkers for Parkinsonian Syndromes, Their Progression, and Pathological Relevance

Project Summary/Abstract
Parkinsonian syndromes (PS) are common and progressive neurodegenerative disorders that encompass
a spectrum of movement disabilities. Despite their distinctive pathological signatures and patterns of brain
changes, PS cause overlapping motor signs including bradykinesia, rigidity, and/or tremor, probably due to
shared dysfunction of basal ganglia (BG)- and cerebellar-related structures. The current diagnosis and staging
of PS as well as other neurodegenerative diseases are based on the pattern of neuronal cell loss or death,
gliosis, and molecular markers. Among PS, the most common form is Parkinson's disease (PD), defined
pathologically by neuronal loss in the substantia nigra (SN) of the BG and presence of α-synuclein (αSyn) positive
Lewy body (LB) aggregation, although many other regions also are involved. Progressive supranuclear palsy
(PSP) and multiple system atrophy (MSA) are also common PS, and are known for neuronal loss in different
brain regions including the BG, pons, cerebellum, and related structures. PSP characteristically has tau-positive
inclusions in both glia and neurons, whereas MSA typically has glial cytoplasmic inclusions that are α-Syn
positive. Currently, no in vivo biomarkers are approved to differentiate these clinically similar syndromes, capture
the distinctive pathological pattern and molecular characteristics, and/or track the progression of each PS. The
literature and our preliminary data lead to our premise that combining state-of-the-art multimodal MRI (Aim
1) with biofluid markers of misfolded αSyn and tau (Aim 2) will yield objective and quantitative
biomarker(s) that provide complimentary information about PS, differentiate PS from each other,
quantify disease progression, and provide insights into the unique neuropathology associated with each
PS. Since 2012, the Penn State team led by Dr. Huang, supported by the NINDS PD Biomarker Program, has
recruited and studied a cohort totaling 270 PS patients (120 PD, 27 PSP, 30 MSA) and 93 Controls. Data
collected to date include longitudinal multimodal MRI (T1, T2, diffusion & susceptibility), clinical data (NIH
common data elements-CDE), and biofluids (plasma, serum, & CSF). We also have 24 postmortem brains from
this cohort. The proposed study will be especially cost-efficient by leveraging this existing cohort, data, and its
banked biofluids, and will expand the sample size of PSP and MSA patients. This will yield a total dataset of ≥60
subjects in each PS and control group for cross-sectional analyses, ≥40 in each PS and control group for
longitudinal analyses, and ≥60 postmortem brains by 2023. In collaboration with the team led by multi-PI Dr.
Kanthasamy (Iowa State), Aim 1 will determine the distinct patterns of MRI in PS and their clinical/pathological
substrates. Aim 2 will test exosomal misfolded αSyn and tau as biomarkers for PS & their progressions. Aim 3
will combine multimodal MRI & misfolded αSyn/tau to discriminate PS/delineate progression. The successful
completion of these Aims may reveal biomarkers that would be of importance in the clinical and differential
diagnosis of PS, and in assessing potential disease-modifying therapies.

Public health relevance
Project Narrative A lack of biomarkers for differentiating Parkinson’s disease (PD) from a number of similar conditions such as progressive supranuclear palsy (PSP) and multiple system atrophy (MSA) (often referred to as atypical parkinsonism), has hindered clinical practice, and basic and translational research. Efforts from many groups including ours have shown that multimodal brain MRI and biofluid measurements of misfolded α-synuclein and tau proteins have great potential for differentiating these similar conditions by reflecting both the pathoetiological process and patterns of changes associated with different parkinsonian syndromes. Leveraging a unique existing cohort, dataset, and banked biofluid, and based on strong pilot data, the current study aims to determine the ability of these “multi-domain biomarkers” in discriminating these similar clinical syndromes, capturing the distinctive pattern of pathological changes associated with each, and tracking their progression. If successful, the proposed studies, in the near future, will deliver the most recent biomarker advances to clinical practice and translational research, and facilitate the basic understanding of this group of diseases.